Epitranscriptomic Mechanism in pathogenesis of Alzheimer’s disease

Contact PD/PI: Jiang, Lulu Epitranscriptomic Mechanism in Pathogenesis of Alzheimer's disease
PROJECT SUMMARY
The accumulation of microtubule-associated protein tau (tau) aggregates intricately parallels cognitive
decline in Alzheimer's disease and related disorders (ADRD), underscoring its paramount importance in
maintaining neuronal health. Yet, despite this association, the precise cascade through which tau aggregation
induces neuronal toxicity remains elusive, representing a significant gap in our understanding of ADRD pathology.
Recent proteomic and transcriptomic analyses of post-mortem AD brains consistently highlight dysregulation in
RNA metabolism and protein translation, hinting at complex molecular underpinnings. Emerging evidence
suggests that tau pathology instigates translational inhibition, dampening protein synthesis and triggering
neuronal dysfunction. However, the elusive molecular mechanism governing tau-mediated regulation of protein
translation remains a central enigma, underscoring the need for further investigation. In particular, our recent
findings in the interaction of RNA modification with tau aggregation unveil novel insights into tauopathy
pathogenesis. We have uncovered a striking elevation of cytoplasmic RNA methylation in human AD cases,
shedding light on a new avenue for exploring disease mechanisms and developing disease-modifying strategies.
The project aims to elucidate the role of RNA modification in ADRD by focusing on deciphering the dynamics of
N6-methyladenosine (m6A) RNA modification in AD progression, by determining the impact of RNA methylation
on AD pathogenesis, and assessing the treatment effect of inhibiting excessive RNA methylation in a mouse
model of AD. The premise of the study is based on the identification of elevated m6A levels in post-mortem brain
tissue of AD patients, particularly in neurons affected by tau aggregation. Our study revealed that oligomeric tau
sequesters m6A-modified RNA, leading to translational inhibition and neuronal dysfunction. I hypothesize that
dysregulated RNA modification and protein translational inhibition induced by tau aggregation mediate the
pathogenesis of AD and related tauopathies. In Aim 1 of the current research, we seek to decode the
epitranscriptomic profiles impacted by tau pathology using m6A DART-seq, aiming to improve understanding of
AD pathogenesis on an epitranscriptomic level. In Aim 2, we will determine the role of RNA methylation in AD
pathogenesis using 3D neuron-glial brain assembloids, targeting m6A methyltransferase and demethylase.
Preliminary data indicates a protective effect of the Mettl3 inhibitor, STM2457, in delaying disease progression.
In Aim 3, we aim to evaluate the therapeutic impact of inhibiting excessive RNA methylation in a humanized tau
and APP double transgenic mouse model of AD. We will investigate treatment protocols targeting the m6A 'writer,'
Mettl3, and the 'eraser,' ALKBH5, as this model recapitulates crucial aspects of AD pathology. Overall, the project
aims to provide new insight into brain m6A as a novel layer of complexity in gene expression regulation in AD
and related tauopathies. It will shed light on the molecular mechanisms of neurodegenerative diseases at the
epitranscriptomic level, potentially leading to new therapeutic strategies.

Public health relevance
Contact PD/PI: Jiang, Lulu Epitranscriptomic Mechanism in Pathogenesis of Alzheimer’s disease PROJECT NARRATIVE Our research aims to uncover the role of RNA modification in Alzheimer's disease (AD) progression, focusing on the N6-methyladenosine (m6A) modification. We discovered that oligomeric tau aggregates sequester m6A- modified RNA, inhibiting protein translation and leading to neuronal dysfunction. By deciphering the dynamics of m6A-RNA modification and investigating its impact on AD pathogenesis using advanced models and therapeutic interventions, we aim to provide insights into novel therapeutic strategies targeting RNA methylation to mitigate neurodegeneration in AD and related tauopathies, thereby offering a new perspective on disease mechanisms at the epitranscriptomic level.